Optimization of CAR-Bacteria for Oral Cancer

ABSTRACT
The goal of this project is to explore the feasibility of generating Chimeric Antigen Receptors (CARs)
expressed by bacteria. Instead of using T cells, we propose to explore the idea and use of bacteria to mediate
the targeted destruction of cancer cells. In addition, we explore the possibility that we could target CAR-bacteria
to specific major histocompatibility complex (MHC)-neopeptide complexes (pMHC) on tumor cells. We call these
engineered bacteria cells CAR-bacteria. Current CAR-expressing T cells provide durable responses but have
three main limitations: specificity, toxicity, and feasibility. This study will address all three concerns. In this
proposal, we target engineered bacterial lysis to head and neck or cervical cancer cells expressing HLA-A2-E7,
a known pMHC on tumor cells infected by human papilloma virus (HPV). The targeting enables anti-tumor protein
production only when a predefined population density of bacteria is reached. This method should dramatically
reduce bacterial colony size and greatly lowers/prevents systemic toxicities. The approach has the potential to
be a therapeutic in HPV-positive oral cancer as it could be administered and controlled as a bacterial mouthwash.
This project combines two innovations leveraging a Synthetically-Evolved Nanobody (SEN) library proven
capable of selectively binding MHC-peptide complexes and combining this specific cancer cell targeting with
synchronized circuit lysis to create CAR-bacteria. Our proposed studies provide proof-of-concept that (1) CARs
can be produced that recognize pMHC, (2) CAR-bacteria localization and colonization can be controlled by tumor
expression of certain pMHC and (3) CAR-bacteria have therapeutic activity against tumor cells that express
specific pMHC. We accomplish these proof-of-concept studies via the following two objectives: (1) Optimize
binding and specificity of CAR-bacteria to HLA-A2-E7 and (2) Check efficacy of CAR-bacteria in an animal model
of head and neck and cervical cancer.

Public health relevance
NARRATIVE This project explores the possibility of creating Chimeric Antigen Receptor bacteria (CAR-bacteria) that can be used to target and destroy cancer cells. We combine the expertise of nanobody-mediated targeting (Chang), cancer immunology (Bui), and a synchronized lysis circuit (Hasty) to create truly novel “bugs as drugs”. Future studies could optimize the circuitry, recognition, and payload in the bacteria to provide even higher therapeutic efficacy.